Community Engagement Core & Science Communication

COMMUNITY ENGAGEMENT CORE - ABSTRACT
The overarching goal of the CEED Community Engagement Core (CEC) is to support the strategic vision of
CEED to address the environmental health concerns of all NJ residents. CEC works with communities and CEED
researchers to characterize the health risks that people face in their daily lives, translate existing research
evidence to action to reduce exposure and risks, and identify new research directions that are aligned with
community environmental health needs. CEC aims to 1) Integrate community environmental health concerns
with the overall CEED vision; 2) Improve environmental health by building capacity in the field and within the
Center to address environmental health risks; and 3) Respond directly to community health needs and concerns
by facilitating community-engaged research (CEnR). To accomplish these aims, CEC establishes and nurtures
active, long-standing relationships with community partners who have common goals to improve environmental
public health. Through regular meetings and bidirectional communications, CEC facilitates sharing perspectives
between community partners and CEED scientists, increasing understanding of community concerns and ways
that environmental health science can address those concerns, reduce risk, and improve health. The CEC
Working Group meets monthly with CEC leadership and Community Advisory Board (CAB) members to plan
activities that include an annual NJ Environmental Health Summit. The CEC builds community capacity to
engage in research through an Environmental Health Ambassadors program and future scientist programs, as
well as CEnR projects addressing community concerns about traffic-related air pollution, legacy and emerging
drinking water contaminants, and other high priority issues. Communication and engagement with community
partners will be enhanced with more opportunities for in-depth dialog and co-learning workshops. Training
modules in environmental public health will facilitate the ability of CEED members and community partners to
participate in review of cumulative impacts assessments and permit decisions under the state’s environmental
regulations. These sessions will build on Center strengths in geospatial mapping, community air monitoring, and
cumulative risk assessment. CEC will support increased participation of community organizations in the Pilot
Project Program by: 1) assisting community-scientist teams with project development; and 2) preparing two CAB
members to participate in the review of relevant pilot grant applications. CEC will work with community partners
to disseminate CEED science. Expanded initiatives in implementation science will identify novel strategies to
enhance translation of CEED science to evidence-based, multi-level interventions that reduce exposures and
health risks. Progress towards the CEC’s goal to translate CEED science to action and impact will be evaluated
by regular benchmarking and soliciting feedback from partners.